Investigating the chromatin landscape of ALT telomeres

PROJECT SUMMARY/ABSTRACT
Cancer cells must initiate a telomere maintenance mechanism to continuously proliferate. While the majority of
tumors (85%) reactivate telomerase, a subset (15%) employs homologous recombination in a process termed
alternative lengthening of telomeres (ALT). ALT primarily manifests in tumors originating from mesenchymal
tissues and is characterized by long and heterogeneous telomeres, the presence of extrachromosomal
telomeric repeats, localization of telomeres in nuclear PML bodies, and telomere sister chromatid exchanges.
Chromatin dynamics play a crucial role in ALT; loss of chromatin remodeler ATRX is almost always observed
in ALT cells, and exogenous expression of ATRX suppress ALT. However, ATRX is a large multifunctional
protein, and the mechanism by which it suppresses ALT remains elusive. Furthermore, H3K9 methylation at
telomeres has been implicated in promoting ALT phenotypes, and loss of H3K9 methylation represses ALT
phenotypes. How H3K9 methylation regulates ALT is also unknown. I hypothesize that ATRX loss promotes
ALT induction by disrupting its role in histone variant H3.3 deposition at telomeres. Further, I hypothesize that
loss of H3.3 disturbs the H3K9 methylation balance at the telomeres, leading to increased H3K9 methylation,
R-loop stabilization, replication stress, and double-stranded breaks driving ALT homologous recombination.
The goal of this proposal is to investigate the chromatin landscape at ALT telomeres and elucidate its
impact on ALT through two distinct but related objectives. In Aim 1, I will focus on the role of ATRX in ALT
suppression. I will employ a base editing screen to create mutations spanning the coding sequence of ATRX.
Using this screen, I will identify ATRX domains and functions that suppress ALT. In Aim 2, I will study the
effect of H3K9 methylation on ALT by manipulating H3K9 methylation specifically at the telomeres. I will then
assess ALT phenotypes and explore the mechanism behind H3K9 methylation’s impact on ALT with a focus on
R-loop stabilization. This work will provide novel insight into how the chromatin state governs ALT and offer
potential avenues to target ALT for cancer therapeutics.
I am an MD/PhD student at the Weill Cornell/Memorial Sloan Kettering/Rockefeller Tri-Institutional Program,
performing the proposed research in the laboratory of Dr. Agnel Sfeir at Memorial Sloan Kettering Cancer
Center (MSKCC). My long-term goal is to become a physician scientist who balances patient care with running
an independent research program at an academic institution. The plan outlined in this proposal, along with the
support and mentorship provided by Dr. Sfeir, my thesis research committee, and the Tri-Institutional
administrative faculty will help me achieve my career goals.

Public health relevance
PROJECT NARRATIVE Cancer cells must activate a telomere maintenance mechanism to continuously proliferate; while 85% of cancer cells reactivate telomerase, 15% utilize a mechanism of homologous recombination termed Alternative Lengthening of Telomeres (ALT). The mechanisms by which ALT is induced and maintained in cancer cells remain unknown. The goal of this proposal is to examine the chromatin dynamics at ALT-positive telomeres, investigate how chromatin state impacts ALT, and assess the potential of leveraging this knowledge for ALT- positive tumor treatments.